Uveitis and Ocular Immunology Fellowship

The National Eye Institute (NEI) uveitis and ocular immunology fellowship encompasses clinical training in the medical and surgical management of patients with uveitis and immune-mediated diseases, with time allocated for research and is an AUPO approved program.

The strength of the fellowship is the breadth of exposure to complex posterior segment uveitic diseases including a number of second opinion referrals. Additionally, fellows have unique exposure to rare diseases such autoimmune retinopathy, vitreoretinal lymphoma (in part through working with NCI) and exposure to the ophthalmic manifestations of rare autoinflammatory diseases.

In addition to this, the GW uveitis rotation (once/week), introduced last year has supplemented the training here in terms of volume and breadth of pathology (including more bread and butter) as well as offering further opportunities for the fellow to mentor and teach residents.

Fellows also participate in a structured curriculum that we have as part of the Thursday morning conference schedule (combination of didactics/ journal clubs/ imaging conference that are generally retina/uveitis focused). We have also held virtual uveitis case conferences/rounds with Cleveland Clinic and Johns Hopkins this past year.

Sunil Bellur (a combined retina/uveitis fellow) was one of 3 recipients of a competitive American Uveitis Society fellow travel grant (open to all uveitis, medical and surgical retina fellows) based on the abstract he submitted.